Mechanisms that Couple Chromatin Modifications to Transcription

Project Summary
The goal of this research program is to elucidate the proteins and mechanisms that regulate transcription
within the context of chromatin, a process critical to every eukaryotic cell. Nucleosomes pose barriers to RNA
polymerase II (Pol II) that must be overcome for accurate and efficient gene expression, and whose properties
and interactions are modulated by post-translational modification. During transcription elongation, a conserved
set of factors assembles with Pol II and facilitates its transit by altering the stability, positioning, and post-
translational modification states of nucleosomes. The proposal addresses three major challenges related to
these functions of eukaryotic transcription elongation factors. (1) What are the mechanisms by which
transcription elongation factors couple chromatin changes, including histone modifications, to RNA synthesis?
(2) How are the patterns of these epigenetic modifications determined? (3) What are the primary versus
indirect functions of core components of the Pol II elongation machinery? These questions will be approached
through a comprehensive analysis of the Paf1 complex (Paf1C) and proteins with which it interacts. Paf1C is a
highly conserved transcription elongation factor that globally associates with Pol II on the bodies of active
genes. The multifunctional nature of Paf1C affords a unique opportunity to reveal how transcription is coupled
to co-transcriptional events. To this end, a multifaceted approach comprising innovative genetic and proteomic
screens, mechanistic biochemistry, and genomics will be deployed. This project will determine how Paf1C
stimulates critical histone modifications and interfaces with a chromatin remodeling factor with genetic links to
prostate cancer. In-depth studies of the interactions between Paf1C and the Pol II elongation complex will
uncover the molecular mechanisms that spatially constrain Paf1C-dependent chromatin changes to active
genes. Finally, the primary and subunit-specific functions of Paf1C, as well as the cellular pathways that
compensate for its absence, will be determined. The studies will be performed in Saccharomyces cerevisiae to
capitalize on the sophisticated tools developed for that system. Given the strong conservation of all proteins
and histone modifications studied, the conceptual advances that arise from this work will have direct
implications for the understanding of gene regulation in humans, where defects in this process cause a wide
range of cancers and other diseases.

Public health relevance
Project Narrative Proper control of gene expression is fundamentally important for the life and development of all organisms. In all eukaryotes, proteins that regulate transcription, a central step in gene expression, operate within the constraints of a chromatin environment that must be properly managed for gene expression to occur without error. This research program will uncover the functions of the Paf1 complex and other conserved proteins in regulating chromatin structure and transcription --- core cellular processes that, when deregulated, cause a multitude of human health conditions, including cancer and developmental defects.